Virus, Vector and Cell Culture Core

Abstract
Core B: Virus Vector and Cell Culture Core
The Virus Vector and Cell Culture Core (VVCCC) will be responsible for 1) recombinant virus design
consultation, 2) vector and viral reagent repository; 3) generation of site-directed mutations in EBV and KSHV
bacmids, 4) large scale production of recombinant and wild-type EBV, KSHV and MCPyV, 5) organoid culture
establishment, 6) infections of organoids with viruses, 7) amplification of primary cultures in vitro post-infection,
and 8) generation of gRNA lentiviral constructs for CRISPR knock out of specific genes. These goals will be
accomplished through a centralized laboratory approach which provides a set of standardized services,
including state of the art methods in herpes virus molecular engineering and recombination-based
mutagenesis (i.e. Kan-SacB, Kan-rpsL, Gal-K, and LoxP-Kan for conditional knock-outs), production of
recombinant Lentivirus expression vectors for cDNA, gRNA and shRNA, and production of EBV and KSHV
from stably transfected HEK-293 cells (recombinant viruses), GFP tagged viruses with specific mutations, or
BCBL1 and LCL1 cells (wild-type viruses), primary and established organoid 3D cultures. Since it is expected
that this program project will generate unique resources for research, the core will be responsible for storage of
recombinant viruses, bacmids, reagents for recombineering and Lenti-virus production, as well as
management of adequate databases that users can access and search via a web-based browser. Expertise in
all aspects of protein and virus production, as well as primary and 3D culture systems will be provided to all
four projects for the lifetime of the program award.

Public health relevance
Narrative: The virus vector and cell culture core will provide a unique resource for the program members that allows streamlined establishments of required reagents using standard operation procedures across all the projects in one core. All vectors, virus preparations and cell cultures will also be standardized, and established for the program members to enhance their research activities and productivity.